Elucidating the role of EYA2 at centrosomes in glioblastoma stem cells

PROJECT SUMMARY/ABSTRACT
Glioblastoma multiforme (GBM) is an aggressive, genetically diverse, and universally lethal
malignancy of the brain. The aggressive characteristics and genetic diversity observed in GBM have
been linked to a population of cells with stem-like characteristics known as glioblastoma stem cells
(GSCs). In collaboration with the Rich lab, we have shown that EYA2 (eyes absent transcriptional
coactivator and phosphatase 2) is highly expressed in GSCs compared to differentiated glioblastoma
cells (DGCs) and neural stem cells (NSCs), where it is highly localized to centrosomes. Importantly,
GSCs are uniquely reliant on EYA2’s tyrosine phosphatase (Tyr Ptase) activity for proliferation, as
pharmacological inhibition of EYA2’s Tyr Ptase activity or overexpression of an EYA2 Tyr Ptase dead
mutant causes cell cycle arrest, mono- and multipolar spindle abnormalities, and apoptosis when
compared to DGCs and NSCs. Together, these data provide evidence that the Tyr Ptase activity of
EYA2 elicits a novel function at centrosomes that is required for GSC proliferation.
We have previously demonstrated that several cancers re-express EYA proteins to promote
tumorigenic and metastatic phenotypes through multiple cytoplasmic and nuclear functions. The Tyr
Ptase activity of EYA proteins is implicated in cell cycle progression in several cancers, but the
molecular cause of these phenotypes is mostly unknown. Intriguingly, EYA proteins have not
previously been shown to function at centrosomes. My data highlights that EYA2 is localized to
centrosomes in GSCs and that inhibition of EYA2’s Tyr Ptase activity leads to centrosome
fragmentation in mitotic GSCs, suggesting a novel, mitotic regulatory role for EYA2 in cancer.
Furthermore, using EYA2 substrate-trapping experiments I have identified several centrosome-
associated proteins and mitotic regulators as potential substrates of EYA2’s Tyr Ptase activity.
Because the precise mechanism for EYA2’s Tyr Ptase activity at centrosomes and in mitotic spindle
formation remains elusive, in this proposal I will test the hypothesis that EYA2’s tyrosine
phosphatase activity is directly required at centrosomes for centrosome maturation and
mitotic spindle formation, and that direct targets of the EYA2 Tyr Ptase activity can be
identified that are critical for mitotic progression.

Public health relevance
PROJECT NARRATIVE: Glioblastoma multiforme (GBM) is the most common brain malignancy in adults and is universally lethal, demonstrating a desperate need for more efficacious therapies. Poor survival outcomes are attributed to tumor recurrence, which is believed to arise from a chemo- and radioresistant, highly plastic population of glioblastoma stem cells. In this proposal we explore a completely novel function for EYA2 in centrosome biology and the molecular mechanism by which it regulates proliferation and mitotic spindle formation in GBM, presenting a novel potential therapeutic target for the disease.